Wetlands in Argentinaas hubs for exchange and emigration of bird-borne arboviruses

Abstract
Arthropod-borne viruses (arboviruses) are emerging at an unprecedented rate due to cultural, biological,
environmental, climatic, and social changes. Historically, considerable attention has been paid to the role of
human-mediated transportation in the dispersal and emergence of arboviruses amplified by birds. However,
few studies have focused on the role of migratory birds as disseminators of these viruses. In most migratory
bird species, seasonal migration consists of a series of consecutive stops where birds rest and feed en route
to their final destination. Wetlands, due to their high stability and productivity, offer excellent habitat for
resident birds as well as stopover and hibernation sites for migratory birds. Consequently, both groups of birds
can reach exceptionally high densities in wetlands. Wetlands are also known to harbor a high density and
abundance of arbovirus vectors, particularly mosquitoes. St. Louis encephalitis virus (SLEV) and West Nile
virus (WNV) are two mosquito-borne flaviviruses amplified by birds. WNV was introduced to the Americas in
1999 and rapidly spread throughout North, Central, and South America. On the other hand, SLEV is endemic
to the Americas. In our country, its role as a human pathogen emerged in 2002. Possibly due to competition
with WNV, SLEV activity decreased in most parts of the United States. However, in 2015, SLEV re-emerged in
the western United States. Phylogenetic analyses confirmed that the (re)emergent SLEV strain belonged to
genotype III, related to a strain isolated in Córdoba, Argentina Representing the first detection of this genotype
in the United States. Recently, we detected the closest common ancestor to the introduced strain in the United
States in a pool of Culex maxi mosquitoes collected in May 2014 in Laguna Mar Chiquita (LMC) in the
province of Córdoba, Argentina. Based on the hypothesis that wetlands represent a hub for exchange and
emigration of bird-borne arboviruses, we propose to characterize the network of vector-host-virus interactions
within MCL/BdRD. To the best of our knowledge, this is the first comprehensive characterization of a wetland
as a hub for arbovirus exchange between resident and migratory birds in the Americas.
This study will: i) identify host bloodmeals in wetland mosquitoes to elucidate the potential viral flow between
resident and migratory birds, ii) analyze the previous exposure of migratory and resident birds to SLE and WN
viruses using serosurveillance, to identify key hosts in transmission networks of these viruses, iii) identify
mosquito species infected with SLE and WN viruses that could potentially act as vectors for these viruses, iv)
describe the phylogenetic and phylogeographic relationships of viral strains circulating in the wetland with
strains previously detected in the Americas region and v) evaluate the vector and host competence role of
Culex mosquito species and urban bird species. While aspects of these transmission cycles have been
studied, this will be the first time they have been integrated in a single, key habitat.

Public health relevance
Project narrative During their movements, birds can disperse infectious agents (bacteria, viruses) and ectoparasites (ticks, fleas, lice) representing an important mode of transport of emerging pathogens. Wetlands are known to serve as hotspots for resident bird diversity as well as a stopover and overwinter sites for migratory birds, since they are stable ecosystems, with high food productivity. We intend to use this study as a foundation to understanding how wetlands works as hub for arboviruses exchange and spillover in an interconnected wetland networks across the Americas.